GCS-CEAS: a novel tool for exposure assessment during disaster response

BRI will develop and demonstrate a Gas Chromatography Selector (GCS) that front-ends a Cavity Enhanced
Absorption Spectrometer (CEAS) for the fast, accurate, selective, sensitive (0.025 ppbv, or better, using pre-
concentration) measurement of a wide spectrum of volatile organic hydrocarbons (VOHs) that are beyond
current CEAS technology. BRI will develop and demonstrate an inexpensive, reusable Pre-concentration
Sample Module (PSM) to collect samples for later analysis. Thus GCS-CEAS significantly extends industry-
leading CEAS technology capabilities for air quality monitoring opening many new applications.
GCS-CEAS will be suitable for mobile applications with a time response comparable to or better than other
gas analyzers (1-2 minutes). Extreme weather events are increasing instances of cascading technological
disasters, e.g., hurricanes damage infrastructure, causing chemical releases, and thus, exposure. GCS-CEAS
addresses the resulting VOHs released and can be expanded to include any gas that can be measured by gas
chromatography. Thus, GCS-CEAS supports disaster response as a reliable, accurate sensor that detects an
extensive range of toxic gases for exposure assessment for first responders and the community.
The GCS-CEAS uses fast (0.1-2 s time response) analysis by the CEAS of CH4 to guide GCS-CEAS data
collection or PSM collection for later analysis. GCS-CEAS can be adapted easily to other VOHs of interest.
Envisioned mobile applications are for cars, a 4WD vehicles, or small ATVs. There are direct health
applications: exposure, breath analysis, diagnostics, or monitoring exhaled anesthetic. GCS-CEAS will be
commercially accessible, requiring minimal technical expertise, maintenance, and calibration.
Fusion of mobile real-time, focused speciation by GCS-CEAS with archival full speciation will transform
source monitoring. GCS-CEAS enables in-plume sample collection that stationary monitors can easily miss or
misinterpret to estimate exposure. Mobile data are snapshot data that removes the large uncertainty in
stationary datasets wherein transport processes and emission unsteadiness become confounded.
We demonstrate field application of GCS-CEAS using remote PSM sample collection downwind of the
Carson Refinery for complete analysis by the bench top system. Tasks involve developing and validating
optimization modules to meet target time response, accuracy, selectivity, and detection limits and accounting
for H2 balance effects on CEAS calibration. Target GCS-CEAS accuracy is 5%. PSM target detection limits are
sub-25 ppt at 1-3 minute time response for BTEX and alkanes, similar to fluorescence analyzer time-scales,
which only measure (selectively) one (not large molecule) gas per analyzer and cannot be re-tasked for other
gases, unlike the GCS-CEAS.

Public health relevance
Chemical disasters can release a vast array of toxic gases with huge health exposure risks to responders and the community and are expected to increase from climate change resultant natural disasters (Bouwer ’19) like hurricanes that cascade into technological disasters (i.e., flood ® oil storage ® oil spill). This SBIR fuses a front-end Gas Chromatograph Selector (GCS), including pre- concentration, to a highly stable, ultrasensitive Cavity Enhanced Absorption Spectrometer (CEAS) analyzer to significantly extends CEAS air quality monitoring beyond the ~20 gases covered to a broad range of Volatile Organic Hydrocarbons (VOHs). GCS-CEAS is suitable for stationary or mobile applications and provides a fast, accurate, robust, portable, real-time, cost-effective, solution for on-site characterization to makes it easier to quickly identify hazardous conditions and assess exposure for responders and at-risk (often disadvantaged) community members.